Mechanisms of CMV Replication on HIV Persistence

Modified Project Summary/Abstract Section

HIV cure efforts will likely continue to be futile if we ignore the inflammatory mechanisms sustaining the persistence of HIV.
Scientific Premise: A common driver of inflammation for persons with HIV (PWH) is Cytomegalovirus (CMV), which almost universally co-infects PWH. During this coinfection, subclinical CMV replication is frequent and profoundly impacts the immune system, including several CMV-driven mechanisms that promote HIV persistence, even during antiretroviral therapy (ART). Some of these mechanisms could skew the HIV provirus towards preferentially integrating into CMV specific CD4+ T cells. Also, as CMV specific CD4+ T cells comprise a large proportion of all CD4+ T cells, so understanding how they contribute to HIV persistence would be essential for HIV cure efforts.
Strengths of the proposed research are that it will use state-of-the-art methods and will leverage prior NIH-investments to collect appropriate biospecimens and data as part of an ACTG-funded, randomized trial of the anti-CMV drug letermovir (A5383, Co-chairs: Gianella, Hunt) as well as anti-CMV vaccine Triplex (A5355, Chair: Sara Gianella).
Study Design: Our project is designed to carefully and rigorously elucidate the CMV-driven mechanisms that impact HIV persistence. Aim 1 will determine how various viral antigens (CMV, Influenza, EBV and HIV) directly induce clonal expansion of HIV-infected CD4+ T cells ex vivo. Aim 2 will assess the indirect effect of suppressing CMV with letermovir or vaccine on HIV reservoirs and T cell repertoire in vivo. To clarify mechanistic pathways of ex vivo and in vivo observations in Aims 1 and 2, we will characterize specific immunologic mechanisms associated with clonal expansion and inflammation in association with CMV and HIV persistence.
Overall Objective: HIV cure efforts will likely be futile if we ignore the inflammatory mechanisms that sustain the HIV reservoir. This project is in line with NIH OAR priorities because it will assess the mechanisms by which viral antigens (CMV, EBV, Influenza and HIV) influence HIV persistence through expansion of CD4+ T cells that carry HIV DNA (Aim 1). Further, we will determine the benefits of suppressing CMV to decrease immune dysfunction and HIV cell reservoirs (Aims 2 and 3).
Impact: The proposed project will have meaningful impact by determining how suppressing CMV with letermovir may influence inflammation, immune dysfunction, and HIV reservoirs. Generated results will advance both the HIV cure and PWH health agendas.

Public health relevance
Modified Narrative Section People with HIV (PWH) are almost always co-infected with CMV, and CMV can hijack the human immune system in ways that allows HIV to persist in the setting of modern antiretroviral therapy. Leveraging clinical trials to collect appropriate samples and data we will test a new CMV drug in PWH, and we will rigorously elucidate the mechanisms of how CMV helps HIV persist, like clonal expansion of CD4+ T cells carrying HIV and exhausting immune responses. By understanding exactly how CMV promotes HIV persistence, we can develop better HIV cure strategies.